Ovarian Function Among Samoan Women with Obesity

PROJECT SUMMARY/ABSTRACT
Obesity is a well-established risk factor for developing cardiometabolic diseases such as diabetes and
hypertension. While the impact of obesity on reproductive health is less understood, studies conducted in high-
income countries have associated obesity with menstrual and ovulatory dysfunction and subsequent infertility.
These findings have significant public health implications for low- and middle-income countries (LMICs) where
access to assisted reproduction treatment remains practically nonexistent despite rapidly increasing obesity
prevalence. Obesity-related morbidity and mortality are particularly high among Pacific LMICs. However, few
studies have assessed the relationship between cardiometabolic and reproductive health in this region.
Previous attempts to characterize menstrual irregularity among Pacific Islander women have relied on
retrospective self-report of cycle length and variability, which is notoriously subject to recall bias and
interlocuter variation. No studies to date have characterized anovulatory cycles among Pacific Islander women.
This is likely because the gold-standard for determining ovulation involves daily transvaginal ultrasonography,
an invasive and resource-intensive procedure that is impractical for epidemiological studies.
My proposal addresses these gaps through two scientific aims and five training aims that leverage an
existing cohort of approximately n=150 Samoan women aged 25-39, whose families Dr. Nicola Hawley
(sponsor) and colleagues have followed since 2015. These women have participated in health and wellbeing
assessments in 2015, 2017/2018, and 2019/2020. During the fourth data collection wave planned for 2022, I
will measure adiposity and prospectively assess ovulatory function. In Aim 1, I will examine associations
between menstrual irregularity and current adiposity and longitudinal trajectories of change in adiposity among
Samoan women. In Aim 2, I will biochemically evaluate the presence or absence of ovulation among regularly
menstruating women and explore the association between anovulation and BMI. Findings will provide critical
insight on secondary infertility among women with obesity and inform the development of protocols for
evaluating female reproductive potential in low-resource settings. Moreover, this project will shed light on the
dual burden of cardiometabolic and reproductive risk among Pacific Islander women, who despite having
among the highest obesity prevalence globally, are underrepresented in epidemiologic research.
My training plan will enable me to develop research, clinical, and professional skills necessary to
become a physician-scientist who conducts longitudinal epidemiologic studies to investigate the impact of
obesity on maternal and child health outcomes in low-resource settings. My training plan outlines coursework,
mentored research, and clinical experiences to enhance my skills in biostatistics, epidemiological study design
and implementation, and reproductive endocrinology.

Public health relevance
PROJECT NARRATIVE Through this F30 training fellowship, I propose to examine the association between adiposity and ovulatory dysfunction among Samoan women. Project findings will shed light on the dual burden of cardiometabolic and reproductive risk among Pacific Islanders, who despite having among the highest obesity prevalence globally, are underrepresented in epidemiologic research. This training proposal integrates new learning experiences in longitudinal data analysis, epidemiological study design and implementation, and reproductive endocrinology which will prepare me for a career as a physician scientist that conducts longitudinal epidemiological research to characterize how obesity affects maternal and child health outcomes in low-resource settings.